BIOLOGICAL STANDARDIZATION OF ALLERGENIC PRODUCTS

Studies of the biological potency of CBER reference grass preparations were carried out. Biologically defined Allergy Units were assigned to reference preparations of the following grasses: Bermuda, June, Meadow fescue, Orchard, Perennial rye, Redtop, Sweet vernal, and Timothy. Candidate reference preparations of Box elder and White oak were also assayed for assignment of biological potency units. A candidate latex preparation was studied in a small number of lates allergic subjects. There is insufficient data to determine whether its biological potency differs from the other reference preparations assayed.